The Use of Transesophageal Echocardiography to Improve Cardiac Arrest Resuscitation Care

Project Summary
The objective of this career development plan and proposed research is to support my development into an
independent investigator focused on resuscitation science, who can successfully conduct mechanism-driven
and patient-oriented research for the development of novel clinical therapies in resuscitation and
cardiovascular critical care. Out-of-hospital cardiac arrest (OHCA) is a leading cause of death in the U.S. and
worldwide with less than 20% of patients surviving to hospital discharge and many survivors experiencing
neurologic injuries. Resuscitation guidelines have espoused treatment recommendations in the delivery of
high-quality cardiopulmonary resuscitation (CPR) and the evaluation for underlying causes of OHCA. However,
despite these approaches, a substantial number of patients do not survive, suggesting a crucial need to seek
new strategies in resuscitation care. Obstruction of the left ventricular outflow tract (LVOT) by chest
compressions has been identified as an important factor causing ineffective CPR, but neither the
hemodynamic nor the clinical impact of this has been well-established. Due to its endoscopic location,
transesophageal echocardiography (TEE) can visualize the heart during the delivery of CPR, conveying unique
real-time and actionable data. This K23 resubmission proposal builds upon prior work by our team
demonstrating that TEE can be deployed rapidly and safely during resuscitation of OHCA patients, providing
high-quality dynamic imaging of the heart and major vascular structures during CPR. Furthermore, since the
original submission our team has successfully implemented a multi-center registry with 25 centers currently
participating, and demonstrated the feasibility to obtain clinical, hemodynamic, and TEE data in patients with
OHCA and in-hospital cardiac arrest. Leveraging this unique experience and infrastructure, as well as a
multidisciplinary team of content-specific mentors, the objectives of this proposal are to perform focused
clinical investigations, aimed to quantify the hemodynamic and clinical effects of TEE-guided CPR, and to
elucidate the barriers to successful implementation of this intervention in acute care settings. In Aim1, I will
leverage the existing infrastructure of our ongoing research network to conduct a multicenter observational
cohort study of adults with atraumatic SCA, aimed to evaluate the impact of TEE guidance of CC location on
hemodynamic endpoints and survival to hospital discharge. In Aim 2, using a mixed methods approach, I will
characterize the implementation determinants, barriers, and facilitators of TEE-informed resuscitation. The
results of this research could enhance the effectiveness of CPR, provide the basis for a novel patient-centric
approach with the potential to impact over 400,000 patients with cardiac arrest annually in the U.S. The
proposed activities will provide the PI with unique skills in the areas of pragmatic clinical trials, cardiovascular
physiology, and dissemination and implementation science, required to develop, evaluate and implement
interventions to improve survival and neurological outcomes from cardiac arrest.

Public health relevance
Project Narrative Despite much research in this area, cardiac arrest remains one of the leading causes of death and an important cause of neurological disability in the U.S, suggesting the crucial need to seek innovative strategies to improve resuscitation outcomes. This re-submission K23 proposal aims to understand the physiology, impact in clinical outcomes, and the determinants of implementation success of a new resuscitation strategy involving the integration of transesophageal echocardiography (TEE), aimed to improve the efficacy of cardiopulmonary resuscitation in cardiac arrest patients. If successful, this novel approach has the potential to transform resuscitation care and improve clinical outcomes for cardiac arrest.